ANALYSIS OF SEAFOOD PROCESSING INJURIES/ILLNESSES

The goal of this study is to improve understanding of the factors and emerging trends associated with occupational injuries in the seafood processing industry in Alaska. Information generated by this study will provide a basis for planning preventive strategies to reduce the incidence of work-related injuries among seafood workers. The specific aims of this study are: 1. Develop a demographic profile of workers injured in the seafood processing industry from 1985-1987. 2. Describe emerging trends in occupational injury patterns in the seafood industry from 1985-1987. 3. Describe those factors associated with seafood processing injuries and identify the direction and strength of the relationship among these factors. 4. Identify those factors that best predict the nature and severity of seafood processing injuries. 5. Compile findings in a booklet to disseminate to fish processing industries and planners and various health care providers who serve the processing industry. This is a descriptive study. Pre-coded Workmen's Compensation Data of occupational injuries/illnesses in Alaska will be re- analyzed using bivariate and multivariate statistical tests. A modified epidemiological framework will guide the conceptual analysis and interpretation of the data. Significant findings and recommendations will then be published in a report for distribution.